Administration (ADMIN)

PROJECT SUMMARY – ADMINISTRATION
The Salk Cancer Center (SCC) has a longstanding tradition of exceptional basic and translational science
research. SCC Administration (ADMIN) provides critical infrastructure and carries out a diverse set of functions
to ensure that all SCC activities run smoothly and efficiently. Toward this goal, ADMIN supports the SCC Director,
Deputy Directors, Program Leaders, Shared Resources (SRs), SCC members, External Advisory Board (EAB)
members, external stakeholders engaged in cancer research, training/education programs, and diversity
outreach efforts. During the current funding period, ADMIN has undergone a major transformation to improve its
impact, value, efficiency, and alignment with CCSG guidelines. Outcomes: Under the strong leadership of SCC
Director Reuben Shaw and Deputy Director for Research Administration Leona Flores, PhD, ADMIN achieved
many accomplishments over this grant period. These include: 1) helping to develop and implement a new
Strategic Plan, 2) coordinating a major restructuring of the organizational leadership and the two SCC Research
Programs presented in this application, 3) providing central programmatic leadership and coordination to foster
and improve collaboration and facilitate communication between SCC investigators, Programs, projects, Shared
Resources (SRs), and other Center participants, 4) reorganizing and expanding the ADMIN staff structure with
expertise in finance, SR management, grants administration, data analytics, and communications, 5) revamping
SCC Program membership to enhance cancer focus, 5) strengthening efforts to improve reporting on grants,
publications, pilot awards, and budgets, 6) providing support to recruit and onboard new external faculty, and 7)
coordinating ramp-down and resumption of SCC activities during the COVID-19 pandemic. In the next grant
period, ADMIN will continue to execute the initiatives within the new SCC 2023-2028 Strategic Plan by providing
critical support to: hasten the pace of cancer discovery; recruit new high-impact, collaborative faculty; increase
the impact of training and education; implement diversity, inclusion, and URM outreach efforts to diversify the
SCC workforce; and foster new team science grants through targeted RFAs and administrative activities that
foster new collaborations. ADMIN supports all governance and programmatic meetings and retreats. It is
responsible for general administrative services; financial management; information technology and systems
development; strategic, program and technology planning; and research resources management. SCC ADMIN
is recognized as an independent entity within Salk Institute, equivalent to that of a department, and works closely
with other offices within the Salk Institute, including Finance, Grants Development, Human Resources,
Information Technology, Diversity Equity & Inclusion, Education Outreach, the Chief Science Officer, and
External Relations to facilitate the vision and goals of SCC.